CORE B: Behavioral Economics and Intervention Science (BEIS) Core

PROJECT SUMMARY
CORE B: Behavioral Economics and Intervention Science (BEIS) Core
The Vermont Center on Behavior and Health (VCBH) is a multidisciplinary research center located at the
University of Vermont (UVM) that investigates relationships between personal behavior and risk for chronic
disease and premature death. The overarching aim of the VCBH Behavioral Economics and Intervention Science
(BEIS) Core is to provide investigators with scientific and technical expertise and research infrastructure in the
three key areas of Decision Making, Intervention Sciences, and Economic Modeling. We propose that Stacey
Sigmon, PhD continue as BEIS Core Director. Our Decision-Making team has administered 1,192
comprehensive executive function batteries to 700 participants in studies led by 10 VCBH investigators, ranging
from efforts to understand executive function among dysregulated children, loss aversion and delay discounting
among smokers to factors underlying variability in response to interventions to manage type 1 diabetes in young
people. Our Intervention Sciences Module has supported studies evaluating novel behavioral and
pharmacological interventions in vulnerable populations, including interventions to treat PTSD among patients
with OUD, engagement in cardiac rehabilitation following myocardial infarction, smoking cessation among
pregnant women, utilization of contraceptive services by women with OUD, and technology-assisted interim
buprenorphine dosing for individuals with OUD. The BEIS Economic Modeling team has supported investigators
in examining the behavioral economic principles underlying problematic drinking among college students, cost
savings from telehealth screening for diabetic retinopathy, the economic impact of sudden unexpected infant
death, cost-effectiveness of onsite contraceptive services for women at risk for unintended pregnancy, financial
incentives for smoking-cessation among pregnant women, and adherence to cardiac rehabilitation after
myocardial infarction. Taken together, we are confident that continuation and further development of this core’s
dedicated service modules and teams will contribute considerably to ensure the impact and sustainability of
VCBH in advancing scientific knowledge and improving clinical care in behavioral health at local, national, and
international levels.